Triglyceride-rich lipoproteins and abdominal aortic aneurysm growth and progression

ABSTRACT
Abdominal aortic aneurysm (AAA) is a life-threatening condition in which aneurysm growth through progressive
dilatation of the abdominal aorta leads to rupture. The only efficacious therapy to prevent or treat rupture is open
or endovascular surgical repair. Non-surgical therapies are desperately needed to prevent aneurysm growth and
protect from rupture, while averting the need for operative repair.
Our recent findings from a comprehensive genome-wide association study (GWAS) suggest that triglyceride-
rich lipoproteins (TRL) are a key mediator of AAA. TRL enter circulation from an endogenous pathway via the
liver as very low-density lipoprotein (VLDL) and from an exogenous pathway via the intestine as chylomicrons.
In plasma, TRL undergo rapid catabolism by lipases into remnant particles that are proposed to promote
atherosclerosis. Because of this, numerous TRL-targeted therapies are in clinical development.
Our published and preliminary data support the involvement of TRL in AAA pathobiology including: (1)
human genetic experiments implicating non-high-density lipoprotein cholesterol (nonHDL-c) over low-density
lipoprotein cholesterol (LDL-c) as the likely causal lipid fraction; (2) a genome-wide significant association
between a missense variant in lipoprotein lipase which increases TRL and AAA risk; (3) genetic data implying a
causal relationship between apolipoprotein A5 (ApoA5) levels (a regulator of circulating TRL) and AAA risk; (4)
elevated TRL in angiotensin II (AngII)-infused mice augmenting the development, growth, and rupture of AAA.
Despite the robust evidence, significant knowledge gaps persist: positioning emerging TRL-targeted
therapies as a non-surgical treatment of AAA requires definitive causal evidence of their role in AAA growth and
progression rather than merely susceptibility. Furthermore, mechanistic data linking TRL to AAA growth and
progression is non-existent. These key knowledge gaps temper enthusiasm for the large-scale efficacy
trials that will be necessary to position emerging TRL-targeted therapies to treat AAA.
To build evidence to support clinical efficacy trials, we will test the central hypothesis that TRL concentration
and composition contribute to both AAA susceptibility/development and growth and progression in humans and
multiple AAA mouse models. Aim 1 will quantify the relationship of TRL concentrations and composition with
AAA growth and progression using human genetics approaches. Aim 2 will determine the mechanistic link
between elevated TRL and AAA growth and progression using mouse AAA models. This application draws
upon a strong collaborative team encompassing expertise in human genetics (Drs. Damrauer and Levin),
lipoprotein biology (Dr. Temel), and mouse AAA models (Drs Lu, Daugherty, and Tsao). We expect that the
proposed project will provide new translational insights into understanding the causative associations between
TRL and AAA growth and progression and yield viable targets for non-surgical therapy of AAA.

Public health relevance
PROJECT NARRATIVE Abdominal aortic aneurysm (AAA) is a life-threatening condition in which aneurysm growth marked by progressive dilatation of the aorta leads to rupture for which the only current treatment is open or endvoascular surgery. The proposed project aims to provide new insights into the causal mechanism linking triglyceride-rich lipoproteins and AAA growth and progression. We will quantify the relationship of triglyceride-rich lipoprotein concentrations and composition with AAA growth and progression using human genetics and mouse models thus paving the way for non-surgical therapies.